UofL RBL Pandemic Preparedness and Response Integrated Research Core

SUMMARY: PANDEMIC PREPAREDNESS AND RESPONSE INTEGRATED RESEARCH SERVICES CORE
The Pandemic Preparedness and Response Integrated Research Services Core (PaPR Core) shall support all
Risk Group 3 (RG3) pathogen studies conducted at the University of Louisville (UofL) Regional Biocontainment
Laboratory (RBL). In alignment with the NIAID Pandemic Preparedness Mission, the PaPR Core shall serve
investigators at UofL, our regional academic and industrial partners, collaborating investigators in the NBL/RBL
network and other investigators who wish to avail of our facilities and expertise. The PaPR Core supports funded
research programs by providing scientific expertise on study design, labor to support execution of both in vitro
and in vivo BSL-3 studies, and data analysis and interpretation services that culminate in issuing a
comprehensive study report to the sponsor investigator. The PaPR Core shall operate on a cost-recovery
business model, with revenue re-invested in core services. The aims of the PaPR Core are to: (1) Support
continuous refinement of RG3 pathogen infection models established at UofL RBL.; (2) Support continuous
refinement of RG3 pathogen infection models established at UofL RBL; (3) Enable investigations on the impact
of aging and chronic metabolic disease on RG3 pathogen infections; and (4) Enable studies on the impact of
environmental toxicant exposure on RG3 pathogen infections.